Collaborative Development of Ethical Report-Back Guidelines for HouseholdExposure Research

Home-based exposures and poor housing quality contribute to health. problems including asthma, lead poisoning, reproductive disorders, etc.. Household exposure research can inform prevention and mitigation strategies. Responsible report-back of individual-level research results (RBRR) from household exposure studies is essential to inform behavioral, housing infrastructure, c, and solutions to improve health. While high level report-back principles have been developed for environmental health research, these do not provide specific guidance on the unique ethical challenges of household exposure research. RBRR for household exposure studies raises a number of ethically contentious issues related to the actionability of results, participants’ housing status (e.g., income level, owner/renter, public/private housing), and the interests of third parties (including family members, neighbors, health professionals, landlords and community leaders), among others. This project aims to develop guidelines for RBRR for household exposure studies in ways that respect participant preferences and communicate information appropriately. We build on a longstanding community partnership with Rochester Energy Efficiency and Weatherization (RENEW) and actively involve a Stakeholder Advisory Board that represents the perspectives of community groups, housing providers, IRBs, public health professionals and others who may be affected by RBRR. We integrate prior report-back studies by recruiting participants from several past housing exposure research studies, including the recently completed Rochester-based ROC HOME study, to provide formative input to Aim 2. Successful completion of this project will result in: (Aim 1) a philosophically and empirically-informed typology of the key ethical questions faced by researchers during RBRR of household exposure studies; (Aim 2) a tool for eliciting participants’ preferences for RBRR in household exposure research; and (Aim 3) decision-support guidelines to help research teams return individual results responsibly. Our collaborative approach will use a rigorous transdisciplinary framework to fill a crucial gap in report-back guidance for household exposure research and will serve as a model for future research on report-back of environmental and non-genomic research results.

Public health relevance
The overall goal of this project is to investigate the ethical questions that arise during the return of individual research results to participants involved in housing exposure studies. It will result in guidelines for household exposure results report-back guidelines for researchers that are informed by participants in prior research studies and by other stakeholders. These guidelines will build the ethical competency of housing exposure researchers as they work to responsibly return results to participants in ways that build trust and inform appropriate solutions.